Academic Leadership Career Award

Program Summary/Abstract
Recent summits and national reports have emphasized the need for more rigorous methodology when
designing, evaluating, and disseminating/implementing dementia care interventions. The short-term career
objective of this Academic Leadership Career Award is to further develop my expertise and leadership in
dementia care intervention science by developing and successfully delivering the Advanced Behavioral
Intervention Design in Dementia Care (ABIDDC) program to pre-doctoral and post-doctoral trainees (n = 12).
By successfully building and delivering the ABIDDC, I will be better positioned to achieve my long-term career
objective: the creation and leadership of sustained infrastructure at the University of Minnesota (UMN) that
cultivates new/early stage investigators and serves as a national resource for dementia care intervention
science. The Specific Aims of the K07 are as follows: 1) Create and deliver a graduate curricula in
advanced dementia care intervention science; 2) Establish a robust mentoring program to support early career
investigators in dementia care science; and 3) Leverage existing support at UMN to position trainees to launch
successful, independent careers in dementia care science. If the Aims of the proposed K07 are achieved, I
anticipate assuming a leadership role in providing the infrastructure, training, and support necessary to
cultivate a cadre of early career investigators and other investigators across the U.S. who are prepared to
conduct state-of-the-art dementia care science.

Public health relevance
Project Narrative Although considerable investment in dementia care science has occurred, questions continue as to whether the existing evidence base is sufficient to warrant widespread dissemination and implementation of innovations to improve the health and well-being for people living with dementia and their caregivers. My short- term career career objective and the focus of this K07 is to implement graduate curricula, extensive mentoring, and robust support to enhance pre- and post-doctoral training in the science of dementia care interventions (the Advanced Behavioral Intervention Design in Dementia Care program). The long-term objective that will result from the proposed K07 is the creation, leadership, and maintenance of infrastructure at the University of Minnesota that serves as a national resource for advanced methodology in dementia care intervention science.